MRI-compatible high resolution microendoscopic system

The requested instrument, the OASIS Implant Microendoscope, represents a revolutionary
advancement in the methodology of translational research. The unique device is engineered in
such a way that mitigates much of the limitations of other available imaging implants. Its
lightweight and electronic-free headmount allows more natural behavior to be exhibited, as it is
designed to enable the subject animal to respond as freely as possible to its environment.
Furthermore, it permits researchers to simultaneously report direct observations of neuronal
activation obtained through the implant microendoscope and indirect observations via functional
Magnetic Resonance Imaging (fMRI). This method of interrogation is likely to yield incredibly
robust empirical findings. Specifically, the proposed projects that will utilize the device will aim to
identify the developmental and cellular mechanisms of resting state fMRI, the effects of neonatal
anesthesia on brain tissue oxygen dynamics, and understand the physiology of the raphe
magnus and its role in visceral pain. At present, NorthShore University HealthSystem does not
currently possess an instrument capable of conducting this type of research even though the PI
already has obtained the necessary experience and expertise to safely and effectively operate
the device with immediate effect. The OASIS Implant Microendoscope along with the
enthusiastic institutional support will unquestionably facilitate the progression of research in line
with the mission of NIGMS as well as NorthShore University HealthSystem by enabling
immediate and impact-driven research to preserve and improve human life.

Public health relevance
Functional magnetic resonance imaging (MRI) has recently experienced an increased interest and growth of its applications in both children and adults. An MRI-compatible high resolution microendoscopic system would greatly enhance the understanding of the cellular mechanisms behind functional MRI, which is required for correct interpretation of the clinical and animal data.